Biospecimen Core

BIOSPECIMEN CORE – PROJECT SUMMARY
The Biospecimen Core will support all P01 Projects by providing high-quality, clinically annotated biospecimens,
services, and expertise. There are three main goals of the Biospecimen Core: 1) Prospectively bank
biospecimens. The Core will oversee the processing and preservation of research and clinical specimens
obtained during all four Projects. The Core will also standardize methods for sample cryopreservation, preclinical
model creation, and ensure authentication of all models. The Core will ensure that essential pathological, clinical,
and family history information needed for conducting a wide range of translational research activities are
collected. 2) Track and share biospecimens. The Core will facilitate the sharing of biospecimens within the P01
team and with the broader research community. The Core will maintain a database that tracks biospecimens
and includes important clinical and pathological information and specimen imaging. The Core will develop plans
for collecting and distributing specimens. 3) Provide pathology services and specimen quality control. The Core
will provide virtual pathological and quality control evaluation of all biospecimens. Blinded review by multiple
pathologists and quantitative evaluation using HALO AI will ensure reproducible assessment of specimens
obtained from both human and mouse tissues. The Core will standardize protocols for immunohistochemistry as
well as purification of single cells, protein, DNA and RNA across all Projects. The use of a shared Biospecimen
Core will enhance collaboration across the Program while ensuring that biospecimens are continuously tracked,
high-quality, and expertly annotated. By providing these services, the Biospecimen Core will help the P01
achieve the goal of identifying the most promising progestins for the treatment of endometrial cancer and atypical
endometrial hyperplasia and the patients who are most likely to benefit.

Public health relevance
BIOSPECIMEN CORE – PROJECT NARRATIVE Progestins are the only pharmacological option for treating early-stage/low-grade endometrial cancer and atypical endometrial hyperplasia; however, the best progestin to use and the patients most likely to benefit remain unknown. The goal of the Program is to identify progestins that are effective and safe as well as biomarkers that predict progestin response. The Biospecimen Core will contribute to this goal by providing specimen banking, tracking, and sharing as well as pathological evaluation and standardized protocols, which are critical to the success of the P01.